2024 Neurobiology of Drug Addiction Gordon Research Conference and Gordon Research Seminar

Project Summary
In this R13 application we request support for the 3rd Gordon Research Conference (GRC) on “Neurobiology
of Drug Addiction,” which will take place in August 2024 in Maine, USA. The objectives of this GRC are to
foster open discussion of novel research developments, build new collaborations, and propel the next
generation of both scientific advances in addiction research and addiction neuroscience researchers. To
achieve these objectives, we will pursue the following four specific aims at the meeting: 1) Provide an
international forum to brainstorm about cutting edge, multidisciplinary research at the forefront of addiction
neuroscience; 2) Introduce breakthrough neuroscientific techniques that facilitate the understanding of brain
mechanisms driving compulsive drug use and relapse; 3) Promote interactions among diverse young and
senior investigators and exchange of ideas that will shape the future directions of addiction neuroscience; and
4) Foster development of the next generation of diverse addiction researchers by encouraging the participation
of students and postdoctoral fellows who are committed to addiction research.
The conference focuses on presentations and discussions at the frontiers of addiction research. The scope of
the lectures will be confined to basic and clinical studies involving addictive drugs (including alcohol) and the
nervous system and will focus on mechanisms of compulsive drug use and relapse. The meeting will also
break down barriers to progress by uniting investigators with synergistic and complementary expertise in areas
ranging from molecular mechanisms to translational clinical research and addiction theory. The conference will
provide a forum to address the latest developments in addiction research in an open and highly interactive
GRC format, which includes formal talks interspersed with ample discussion time, poster sessions, and
informal discussion periods that cultivate communication and collaborations.
This conference setup differs from that of other meetings in the field and will provide a unique opportunity for
close interactions among investigators at all stages of their careers and among investigators with different
research approaches and cultural perspectives. Concerted efforts to support participation of students,
postdoctoral fellows, young investigators, and members of groups historically under-represented in addiction
research will nurture the growth of the next generation of addiction researchers. As in 2022, we will hold an
accompanying GRS in 2024 to provide a forum for students and postdoctoral fellows; in addition, a substantial
number of GRC talks will be delivered by early career scientists. We envision that the Neurobiology of Drug
Addiction GRC will significantly advance our understanding of the neural mechanisms underlying drug
addiction and stimulate the development of novel hypotheses, research directions, and therapeutic
approaches.

Public health relevance
Project Narrative The third Gordon Research Conference (GRC) on Neurobiology of Drug Addiction will be held in August 2024 in Maine, USA. About 150-200 diverse participants from around the world will attend this five-day meeting to discuss addiction research and treatment. The research presented at this GRC will highlight cutting-edge basic and clinical addiction studies on neurobiological mechanisms of compulsive drug use and relapse.